Decoding the co-evolution of cancer subclones and their ecosystem in TNBC multi-organ metastasis

Ninety percent of cancer-related deaths are due to metastasis, rather than complications from the primary
tumor. For metastatic triple-negative breast cancer (mTNBC) patients, their disease often spreads to multiple
organ sites, such as the lungs, liver, and brain. This high rate of metastatic spread poses a significant challenge
in managing mTNBC, as the disease's ability to disseminate to various organs leads to poorer outcomes.
mTNBCs show extensive intra-tumoral heterogeneity (ITH), making it challenging to study due to both logistical
and technical barriers. Logistically, it is difficult to obtain primary tumors and metastatic sites from multiple
organs from a single patient. Technically, it has been difficult to resolve genetic and transcriptomic ITH from
samples across multiple organ sites, which is critical for reconstructing clonal lineages and ordering the genetic
events that occur during metastasis to understand models of evolution and progression. To overcome these
challenges, our group has established the first metastatic breast cancer postmortem tissue collection program,
‘Final Gift Program’, at the MD Anderson Cancer Center. To overcome technical hurdles, we will leverage a
new, high-throughput, nanowell method to simultaneously measure DNA and RNA in the same single cells and
provide spatial context with new spatial genomic technologies. Our central hypothesis is that development of a
metastatic phenotype is driven by co-evolution of cancer cell intrinsic genomic alterations and their intimate
interactions with the tumor microenvironment (TME) at the primary tumor and metastatic niches at different
organ sites. We will investigate the genomic evolution of primary to metastatic tumor cells by reconstructing
clonal lineages and mapping phenotypic programs to the genetic lineages during metastasis. We will study
metastatic precursor cells (MPCs), which are rare subpopulations in primary tumors that share features with
cancer cells at metastatic sites. By studying gene expression programs found across seeded organs, we will
gain insights into the molecular events that promote metastatic spread. Our proposal is organized into three
synergistic aims. Aim 1 will apply an innovative DNA&RNA co-assay to study the genomic and phenotypic
evolution of MPCs during metastatic dissemination. Aim 2 will investigate gene expression programs in the
stromal and immune TME across multiple organ sites. Aim 3 will integrate the spatial proximity of metastatic
cancer cells and TME cell types to define cancer-immune interactions within each niche. Completing these
aims will greatly expand our fundamental understanding of mTNBC metastasis and the contributions from both
the cancer cells and TME that promote multi-organ dissemination. The long-term goal is to uncover the
genomic and transcriptomic underpinnings of metastatic spread that can be exploited to develop effective
therapeutic interventions for treating or preventing metastases in mTNBC patients. This proposal directly aligns
with the NIH mission to reduce the disease burden and enhance the quality of life for mTNBC patients.

Public health relevance
Triple-negative breast cancer (TNBC) is an aggressive form of breast cancer that frequently metastasizes to the brain, lungs, and liver, yet the genomic and transcriptomic drivers of metastasis are not well understood. We propose to use a cutting-edge single cell DNA-RNA co-assay technology and spatial transcriptomics to study postmortem tissue samples across multiple organs to delineate the genotypic and phenotypic progression of cancer cells and their co-evolution with the surrounding tumor microenvironment. Our proposal is directly aligned with the mission of the NIH to improve the quality of life and decrease morbidity in breast cancer patients.